CAPTOPRIL VERSUS DIURETIC VERSUS PLACEBO ON ANGTIOTENSIN II PLATELET AGGREGATION

The purpose of this study is to determine whether converting enzyme inhibitors, compared with diuretics and placebo, block angiotensin II mediated platelet aggregation.